Advanced Development of Antibacterial Resistance Countermeasures

To support the advanced development of a promising candidate therapeutic for resistant bacteria. The research and development activities to be supported will allow the candidate therapeutic product to progress through the product development pathway, including biodefense pathogens and preclinical and IND enabling development activities, chemistry optimization/development, GMP manufacturing, and clinical safety and efficacy assessment.